Outer Membrane Proteins of Borrelia burgdorferi

Project Summary
Lyme disease has become a worldwide public health problem and is now the most common tick-borne
infection in the United States and Europe. To better understand how Borrelia burgdorferi, the causative agent
of Lyme disease, persists in the infected tick and mammal, many laboratories have focused on identifying and
characterizing outer surface proteins from this spirochete. The interface between B. burgdorferi and its tick or
mammalian host is its outer surface; therefore, outer membrane proteins (OMPs) localized to the surface of
this organism play an important role in virulence and disease. Along these lines, in the last funding period we
focused on characterizing the outer membrane protein system that exports OMPs to the surface of B.
burgdorferi. This OMP export complex, termed the β-barrel assembly machine (BAM), is comprised of three
major outer membrane proteins in B. burgdorferi, the OMP BamA along with two accessory lipoproteins, BamB
and BamD. A second OMP transport system has recently been identified in some dual-membraned bacteria
(i.e., bacteria with both an inner membrane and an outer membrane), which has been named the translocation
and assembly module (TAM) system. The TAM system consists of the OMP designated TamA and a single
inner membrane (IM) protein designated TamB. While the BAM system exports the majority of OMPs, the
TAM system is now known to export various autotransporters and other virulence-associated OMPs. During
our studies characterizing the borrelial BAM export complex, we also identified a hypothetical borrelial protein,
BB0794, which we determined is a borrelial TamB ortholog. Interestingly, almost all dual-membraned
organisms characterized to date have been found to encode a TamB ortholog, but only the Proteobacteria
contain the complete TAM system comprised of both TamA and TamB. The functional role of TamB in all
dual-membraned organisms lacking TamA, including B. burgdorferi, has therefore remained an unanswered
question. Our recent studies, however, may have finally answered this question as we discovered that the
borrelial TamB protein specifically interacts with BamA of the BAM complex. Consistent with TamB being
involved in OMP export and outer membrane biogenesis, we observed that a TamB mutant has altered cellular
morphology and increased sensitivity to antibiotics. The combined findings lead us to propose a new
functional role for TamB orthologs in dual-membraned organisms, such as spirochetes. The underlying
hypothesis of our proposed studies is that a better understanding of the OMP export systems in B.
burgdorferi will lead to the identification of novel virulence factors and vaccine candidates for Lyme
disease. Importantly, the studies we propose in this application could also change the current
paradigm of OMP export and outer membrane biogenesis in many bacterial pathogens.

Public health relevance
Project Narrative Our long-term goal is to characterize the Borrelia burgdorferi outer surface protein export system. A better understanding of this process will allow us to identify novel virulence factors, possible Lyme disease vaccine candidates, and/or disease modulating therapeutics for Lyme disease. Given that the outer membrane protein export machine in B. burgdorferi is conserved, at some level, among all proteobacteria, our studies could also greatly benefit public health worldwide by helping to identify broad-spectrum antibacterials that could be used to treat many different devastating and serious diseases in the United States and abroad.